INTERACTIONS BETWEEN CHEMICAL DOSE AND TOXICITY

Several organohalide compounds are metabolized to reactive intermediates presumed to be the ultimately toxic molecules. The reactive metabolites are detoxified by reacting with tissue non-protein sulfhydryls (NPS), and acute toxicity occurs only when NPS have been depleted below a critical level. Upon prolonged chemical exposure, however, a dynamic state exists between chemical metabolism, NPS depletion, NPS synthesis, and lesion development. Whether or not the same relationship exists between tissue NPS concentrations and the development of lesions in a chronic exposure situation as in an acute one is being evaluated. Also, the organ-specificity and species-specificity of these phenomena are being studied.